Advanced Imaging and Analysis

ADVANCED IMAGING and ANALYSIS MODULE
Project Summary
The goal of the Advanced Imaging and Analysis (AIA) module is to provide our NEI R01 investigators with the
resources and expertise to conduct cutting-edge basic and translational vision research. This module provides
a unique, centralized resource of state-of-the-art microscopes, quantitative image analysis, and the creation
of visual content at levels exceeding the capabilities of any individual laboratory. The modules's shared
resources enhance productivity, promote collaboration between research groups, and ensures the highest
standards of image analysis and visualization for the data produced by our team of vision scientists.

Public health relevance
ADVANCED IMAGING and ANALYSIS MODULE Project Narrative The goal of the Advanced Imaging and Analysis module is to enable visualization of cellular dynamics of ocular tissues with unprecedented spatiotemporal resolution. This innovative module combines state-of-the-art imaging modalities with a unique, centralized resource for quantitative image analysis and creation of visual content across presentation platforms. All our NEI R01 investigators and faculty, staff, and trainees working in vision research use these resources extensively.